How Listeria senses and responds to different host environments

Project Summary/Abstract
Listeria monocytogenes is facultative intracellular food-borne pathogen that provides an extremely
amenable model for basic studies on host-pathogen interactions. During past funding periods, genetic
screens led to the discovery that L. monocytogenes upregulates the expression and synthesis of glutathione
synthase (GshF) during infection and that glutathione is an allosteric activator of the major virulence
transcription factor, PrfA. Mutants lacking GshF fail to fully activate PrfA and consequently form small
plaques in tissue culture cells and are approximately 200-fold less virulent in mice. However, virulence of
gshF mutants was fully rescued by mutations that locked PrfA in its active configuration, referred to as PrfA*
mutants. During the current funding period, we designed a genetic screen with the goal of identifying
additional transposon mutants that formed small plaques in tissue culture cells, but were restored to a wild-
type phenotype when the mutation was transduced into a PrfA* background. In addition to finding the
expected gshF mutants, we found mutants in gloA, which encodes glyoxalase A, the primary component
necessary for the glutathione-dependent detoxification of the reactive electrophilic species (RES),
methylglyoxal (MGO), which is a toxic side-product of glycolysis in both bacteria and host cells. Mutants
lacking gloA were approximately 1000-fold less virulent in mice and like gshF mutants, were restored to full
virulence in a PrfA* background, suggesting that MGO is an in vivo cue leading to GshF synthesis and
activation of PrfA. MGO reacts with both amino acids and guanine causing DNA damage and mutations. In
preliminary data, we confirmed that gloA mutants had a 10-fold increase in their mutation rate when
exposed to MGO in vitro, but strikingly, the mutation rate of gloA mutants was approximately 100-1000-fold
higher in the spleens and livers of infected mice, suggesting that the in vivo environment encountered by L.
monocytogenes is enriched in MGO and consequently highly mutagenic. Double gloA/prfA* mutants were
not only fully virulent, they did not suffer increased mutation rates in vivo, suggesting that in the absence of
GloA, activated PrfA protects against DNA damage by a yet-to-be discovered mechanism. Based on the
literature, we hypothesized that DNA damage caused by MGO was repaired by UvrAB-dependent
nucleotide excision repair pathway. Astonishingly, a uvrAB mutation rescued the virulence defect of gloA
mutants, but unlike PrfA* mutants, gloA/uvrAB mutants still had an extremely high mutation rate. These data
suggest that gloA mutants suffer severe DNA damage in vivo and are killed by the resultant DNA repair
process. In this renewal, we propose to characterize the in vivo environment that causes such a high rate of
mutations in gloA mutants, determine how PrfA mediates GloA-independent protections from MGO, and
lastly explore the hypothesis that gloA mutants are killed by their own DNA repair process.

Public health relevance
Project Narrative Diseases caused by intracellular pathogens remain one of the largest challenges facing the international biomedical community. The proposed studies on the facultative intracellular human pathogen Listeria monocytogenes will provide insight into how pathogens recognize and respond to host inflammation. These studies are relevant to the treatment and prevention of diseases caused by intracellular pathogens.